High-throughput Screening Core

The purpose of the high-throughput screening (HTS) core laboratory (Core B) is to create and conduct HTS screens of small molecules to identify those that can become leads for developing cancer therapeutics or tools in cancer research. In addition, the HTS laboratory conducts genomic RNAi screens to identify novel targets for developing cancer therapeutics. Core B manages the UTSW chemical compound file currently including more than 200,000 small drug-like organic compounds. Core B develops assays for the projects of the PPG,screens them and analyzes screening data. The HTS lab conducts secondary screens required to validate compounds of interest identified during primary screening experiments. Working with the investigators of the PPG, scientists in Core B and the Chemistry Core prioritize the compounds of interest identified in HTS experiments and manage resupply and storage of those compounds. The HTS core maintains an Oracle database of screening data so that the activity of compounds of interest in any HTS experiment can be compared to all other HTS experiments conducted with the UTSW compound file. The HTS Core also manages and conducts HTS screening experiments of a human genomic siRNA library for the Projects of the PPG. In addition to conducting HTS screens for members of this NCI funded PPG, Core B trains and advises members of the Comprehensive Cancer Center at UT Southwestern on the development and execution of small molecule and genomic siRNA HTS experiments and stores the data from such experiments as part of the UTSW screening database. The HTS facility advances cancer research by providing cancer researchers access to hundreds of thousands of structurally diverse compounds from which leads for drug therapeutics or tools for cancer research can be identified.